Chemogenetic Inactivation of the Primate Internal Globus Pallidus as a Treatment for Parkinsonism

PROJECT SUMMARY
Parkinson’s disease (PD) leads to disabling motor impairments, resulting from the degeneration of the
dopaminergic nigrostriatal pathway and a loss of dopamine in the striatum. These pathological changes alter the
neuronal activity throughout the basal ganglia. One of the salient changes is that the activity in the motor portion
of the internal pallidal segment (GPi) is increased and abnormally patterned. The currently available medication
or neurosurgical treatments for the symptoms of PD are encumbered by unwanted side effects that frequently
limit their use in patients. Many of the adverse effects of the current therapies undoubtedly result from their lack
of cellular or brain circuit specificity. Minimally invasive methods to reversibly modulate neurons in a selective
manner in the motor territory of the basal ganglia could provide an alternative approach to alleviate parkinsonism
without side effects. We hypothesize that chemogenetic methods that target genetically specified neurons may
be a safer, and at least equally effective alternative. Chemogenetic techniques involve the expression (through
viral vectors) of artificial receptors in specific neurons. These receptors can then be activated by systemically
administered compounds that are otherwise inert. In the planned experiments, we will use a novel chemogenetic
approach, based on the expression of receptor-modulated ligand-gated ion channels, to reduce GPi activity in
rhesus monkeys that have been rendered stably parkinsonian by treatment with 1-methyl-4-phenyl-1,2,3,6-
tetrahydropyridine (MPTP). The phenotypic and physiologic similarities between MPTP-induced parkinsonism
and PD make the MPTP-treated monkey an excellent model for this purpose. We have strong preliminary results
indicating that the chemogenetic receptors we plan to use (“Pharmacologically selective actuator molecules”
(PSAMs)) can be successfully expressed in GPi neurons of monkeys using viral vectors, and that systemic
administration of PSAM-activating compounds ameliorate GPi activity, with accompanying changes in
movement. We now plan to evaluate the antiparkinsonian effects of PSAM-mediated inactivation of GPi in MPTP-
treated monkeys (aim 1). In the course of these experiments, we will study the effects of acute or chronic
administration of two PSAM-activating compounds (low doses of varenicline, a clinically approved smoking
cessation drug, or a newly generated “pharmacologically selective effector molecule” (PSEM)). The responses
to these drugs will be compared to those of the gold-standard antiparkinsonian medication, levodopa. Under aim
2, we will examine the pattern and longevity of the PSAM expression in the GPi and will histologically verify that
chronic use of these chemogenetic therapeutic methods do not have identifiable neurotoxic effects. The
proposed studies will help us to develop the PSAM approach into a treatment for parkinsonism, that could offer
notable advantages over the currently available therapies.

Public health relevance
PROJECT NARRATIVE Current treatments for the motor symptoms of Parkinson’s disease (PD) are effective but can have significant side effects that limit their usefulness. We propose a novel approach to treat PD, based on modulation of the activity of genetically specific neurons in the brain, rendering them susceptible to activation or inactivation by systemically administered drugs that are otherwise inert. We will study the use of this ‘chemogenetic’ approach in parkinsonian primates, with the long-term goal of developing an effective chemogenetic treatment for PD that has greater specificity and fewer side effects than existing therapies.